Mechanism of Transcription-coupled DNA Repair and its Impact on Cancer Mutations

ABSTRACT
Elongating RNA polymerase II (Pol II) can be blocked by a variety of DNA damage. The stalled Pol II prevents
passage of other RNA and DNA polymerases and blocks exposure of damage to repair proteins, leading to
apoptosis or mutagenesis. To avoid these detrimental outcomes, cells activate several mechanisms, including
transcription-coupled nucleotide excision repair (TC-NER), to rescue the stalled Pol II. In human cells, the
Cockayne Syndrome B (CSB) protein is believed to bind to damage-stalled Pol II and initiate TC-NER.
However, there is a critical gap in knowledge concerning how CSB switches Pol II from elongation to a form
amenable to DNA repair. Additionally, TC-NER is best known to repair helix-distorting (bulky) DNA lesions, but
whether it also repairs non-bulky base damage that occurs more frequently in living cells is poorly understood.
To address these important questions, we developed genome-wide and single-nucleotide resolution
sequencing methods to map DNA lesions, including bulky cyclobutane pyrimidine dimers (CPDs; UV damage)
and non-bulky N-methylpurines (NMPs; alkylation damage). Notably, our CPD-seq data indicates that yeast
Rad26, an ortholog of CSB, functions in displacing the transcription elongation factor, Spt4-Spt5, from the
stalled Pol II. This function of Rad26 is mainly required for gene coding regions downstream of the first (+1)
nucleosome. The eviction of Spt4-Spt5 likely disrupts the closed conformation of the Pol II complex, thereby
switching Pol II from elongation to repair. Furthermore, we identified a subset of genes in which TC-NER
across the entire coding region was independent of Rad26, suggesting both Rad26-dependent and
independent TC-NER mechanisms function in the yeast genome. How CSB functions and whether CSB-
independent genes exist in human cells are unclear. In this proposal, we will utilize an improved CPD-seq
method to generate genome-wide TC-NER profiles in CSB-proficient and deficient human cells. Comparison of
the two repair maps will help identify CSB-dependent and independent genes and guide investigation into their
underlying mechanisms (Aim 1). The binding of CSB to Pol II is the first step for TC-NER. Damage removal
requires the assembly of a large nucleotide excision repair (NER) complex on DNA. TFIIH is the next crucial
NER factor following CSB. Aim 2 will elucidate TFIIH recruitment to test the hypothesis that CSB-mediated
Spt4-Spt5 displacement leads to TFIIH binding to the stalled Pol II. Moreover, our NMP-seq data indicates that
TC-NER also repairs non-bulky alkylation lesions, suggesting TC-NER targets a broader spectrum of DNA
damage than currently appreciated. Aim 3 is based on this intriguing finding and will focus on TC-NER of
oxidative base damage, which is the most frequent endogenous damage with a profound role in cancer
mutagenesis. Hence, these proposed studies will use innovative approaches and significantly improve TC-
NER research by offering genome-wide insights for both bulky and non-bulky lesions.

Public health relevance
PROJECT NARRATIVE This proposal will use genome-wide approaches to investigate transcription-coupled DNA repair in eukaryotes. Studies proposed in this application will help us understand mechanisms of the neurological disorder Cockayne syndrome (CS) and cancer mutagenesis.